Identification of ERalpha/ERbeta Heterodimer-specific Ligands by HTS

DESCRIPTION (provided by applicant): One out of every eight women in the United States will develop breast cancer during her lifetime. The biological actions of estrogens are transduced by its binding to two estrogen receptors (ERs), ERα and ERβ, which have a "Ying and Yang" relationship in regulating estrogen action (i.e., ERα promotes while ERβ inhibits estrogen-dependent cell growth). ERβ is thought to counteract the stimulatory effects of ERα through heterodimerization of the two receptors, and these heterodimers have been proposed to regulate sets of genes distinct from those regulated by either homodimer. However, the mechanism by which ERβ functions in concert with ERα as a heterodimer in breast cancer has not been studied in detail due to the lack of specific ERα/β?heterodimer ligands. We have established highly robust and reproducible Bioluminescent Resonance Energy Transfer (BRET) assays which can distinguish ligands with ability to induce ERα homodimers, ERβ homodimers and ERα/β heterodimers. This proposal outlines three specific aims that focus on high throughput screening (HTS) for identification of ERα/β?heterodimer specific ligands. In Aim 1, we take advantage of an ERE-reporter stably integrated cell line that is amenable to HTS. This T47D-KBLuc cell line expresses both ERα and ERβ, making it feasible to identify compounds transactivating all forms of ER dimers including ERα and ERβ homodimers as well as ERα/β?heterodimers. In Aim 2, estrogenic compounds identified from this primary screening will be subjected to the HTS using BRET. In Aim 3, the identified hits will be tested for their abilities to inhibit growth of breast cancer cells co- expressing ERα and ERβ. Development of a novel system by which ERα/β heterodimers may be studied will provide a means for direct evidence for heterodimer formation in vivo. Furthermore, these tools will allow preliminary exploration of heterodimer function in breast cancer via cell-based assays. PUBLIC HEALTH RELEVANCE: Estrogen receptors (ERs) play essential function in regulating cell proliferation in breast cancer cells;however the biological functions of ERα/ERβ heterodimer remain unknown due to lack of heterodimer-selective compound. Here we propose two-step high throughput screenings for identification of ERα/ERβ heterodimer specific ligands.

Public health relevance
PROJECT NARRATIVE Estrogen receptors (ERs) play essential function in regulating cell proliferation in breast cancer cells; however the biological functions of ERα/ERβ heterodimer remain unknown due to lack of heterodimer-selective compound. Here we propose two-step high throughput screenings for identification of ERα/ERβ heterodimer specific ligands.